Pulsatile Flow Regulation of Vascular Cell Fate

Vascular smooth muscle cell fate decisions (i.e. whether a cell differentiates, proliferates, undergoes apoptosis or migrates) play an important role in the pathogenesis of vascular disease including atherosclerosis, intimal hyperplasia and the arterial response to injury. The Hedgehog (Hh) signaling pathway. Notch receptor-ligand interactions and Vascular endothelial growth factor (VEGF) have all been implicated in vascular morphogenesis and modeling of the embryonic vasculature. Hh signaling occurs through the interaction of the Hh protein with its receptor, patched-1 (ptc1) leading to activation ofa transcription factor, Gli, which induces expression of downstream target genes including Ptcl and Gli. The discovery of angiogenic activity for Hh, preferential Ptcl expression in vascular tissue, combined with its mechanosensitivity in vascular cells and known morphogenic functions suggest that Hh might also coordinate vascular cell fate changes in adult tissue. Notch receptor-ligand interactions are also a highly conserved mechanism that regulates intercellular communication and directs individual vascular cell fate during embryogenesis, and more recently in adult cells following injury. The discovery that SHh acts upstream of Notch and VEGF during arterial differentiation combined with Hh regulation of Notch target genes in a variety of cell types, further support a role for Hh-Notch interactions in controlling vascular cell fate. Given these reports in the literature and our preliminary data supporting hemodynamic regulation of both Hh and Notch signaling components in SMC, our central hypothesis is that Hh mediates flow-induced changes in SMC growth (proliferation and apoptosis) and migration via regulation of VEGF/ Notch signaling

Public health relevance
RELEVANCE (See instructions): Hemodynamic forces, which are associated with blood flow play a fundamental role in maintaining vascular tone, remodeling of blood vessels and associated vascular pathologies. Transduction of these forces can lead to changes in cell growth, death or migration which play an important role in vascular diseases such as atherosclerosis and the arterial response to injury.